Neonatal Research Network Data Coordinating Center (DCC) 2023-2028

PROJECT SUMMARY/ABSTRACT
Advances in the care of premature infants has resulted in younger and more premature infants surviving to
hospital discharge. Critical gaps in research regarding feeding in premature infants require multidisciplinary
involvement to better understand feeding problems alongside the long-term outcomes and healthcare needs of
these infants. NICHD established the Neonatal Research Network (NRN) to investigate persistent unanswered
questions regarding the safety and efficacy of treatment and management strategies for newborn infants. RTI,
as the NRN Data Coordinating Center (DCC) since 1988, is uniquely positioned to provide support to the
Feeding in Premature Infants Working Group. RTI will pull from a highly experienced bench of DCC
coordinators who are up-to-date on the latest advances in neonatal research. Dr. Abhik Das, NRN DCC PI for
the past 17 years, has extensive experience in neonatal clinical studies. He will be assisted by Task Lead, Dr.
Jamie Newman, who has served as the DCC NRN Follow-up Study Coordinator for the past 19 years. As Task
Lead, Dr. Jamie Newman will be supported by a mid-level DCC coordinator to accomplish the following
activities: (1) attend and provide support for Working Group meetings and conference calls with Working Group
Leads and NICHD; (2) draft a report on behalf of the Working Group including assisting with the literature
review and developing the background section of the report.

Public health relevance
PROJECT NARRATIVE NICHD established the Neonatal Research Network (NRN) to investigate persistent unanswered questions regarding the safety and efficacy of treatment and management strategies for newborn infants. RTI, as the NRN Data Coordinating Center (DCC) since 1988, is uniquely positioned to provide support to the Feeding in Premature Infants Working Group and will pull from a highly experienced bench of DCC coordinators who are up-to-date on the latest advances in neonatal research. RTI, as the NRN DCC, will provide support to the Feeding in Premature Infants Working Group and will draft a report on behalf of the Working Group.